Developing and Testing a Population Health Approach to Deprescribing and Optimizing Medications in Older Adults

PROJECT SUMMARY
Michelle S. Keller, PhD, MPH is a health services researcher with Assistant Professor appointments at Cedars-
Sinai Health System (CSHS) and UCLA. Dr. Keller’s research focuses on reducing inappropriate medication use
in older adults, particularly in populations with high levels of medication use, such as older adults with Alzheimer’s
Disease and Related Dementias (ADRD). Reducing inappropriate medication use in older adults has been
shown to reduce mortality, but evidence is limited on whether interventions that reduce inappropriate medications
reduce hospitalizations and emergency department visits. More than half of older adults in the U.S. receive their
care from health systems and provider groups which contract with Medicare Advantage plans or are part of
Accountable Care Organizations, organizations which are financially accountable for Medicare beneficiaries’
health costs. These organizations proactively manage chronic conditions such as diabetes, hypertension, and
high cholesterol to prevent unnecessary avoidable hospitalizations. This proposal aims to create a similar
approach to managing medication use through the development and validation of a risk prediction model and
registry that identifies older adults with a large number of potentially inappropriate medications and other
conditions that place older adults at risk for hospitalization, including age, cognitive decline, frailty, and risk of
falls. This proposal will use this registry and risk model as part of a feasibility and acceptability study to identify,
refer, and enroll older adults with ADRD in a pharmacist-led medication review intervention aimed at reducing
inappropriate medications. Dr. Keller’s career development and training plan includes coursework in embedded,
pragmatic clinical trials and geriatrics. Dr. Keller will accomplish the proposed research and training aims with
the support of a strong multi-disciplinary mentoring team from UCLA and CSHS: Catherine Sarkisian (geriatrics
and deprescribing), Zaldy Tan (ADRD) Teryl Nuckols (health systems science), Joshua Pevnick (medication
management), and Nicole Brandt (pharmacy and deprescribing). These efforts will be supported by the
outstanding research environment and infrastructure of CSHS and UCLA. Given the strong mentoring,
institutional, and infrastructure supports in place, the proposed K award program is ideally designed to provide
the PI with the experience needed to launch her career as an independent investigator and future leader in
deprescribing research.

Public health relevance
PROJECT NARRATIVE The use of unnecessary or potentially harmful medications is a serious problem in older adults, particularly older adults with Alzheimer’s Disease and Related Dementias (ADRD). This project will develop and validate a risk prediction model that identifies older adults with ADRD at greatest need for medication review, will use a registry to monitor medications and risk factors for hospitalization, and will enroll them in a pharmacist-led intervention aimed at reducing potentially inappropriate medications. This proposal will also provide protected time for research and training for Michelle S. Keller, PhD, an early career investigator seeking to be a leader in the field of deprescribing.